Establishing The Validity, Responsiveness, And Appropriateness Of Patient-Reported Outcome Measures For Adult Traumatic Brachial Plexus Injury

PROJECT SUMMARY/ABSTRACT
Adult traumatic brachial plexus injuries (BPI) have a devastating impact on patients, affecting multiple domains
(physical, social, and emotional) of their lives. Prior studies have focused on neurologic and biologic predictors
of severity of injury (such as extent of plexus injury), but little attention has been paid to other predictors of
recovery. A better understanding of how other factors (such as emotional trauma, mental health, pain, and social
support) influence recovery after BPI will provide new insight into ways to optimize outcomes for BPI patients.
The long-term goal of our research program is to develop a national multicenter prospective cohort study of
patients with BPI, assessing outcomes at standardized intervals using a patient-reported, disease-specific
outcome measure that captures the physical and emotional domains of recovery. The objectives of this
application are (1) to determine the outcome measures that best capture the experience of recovering from BPI
and (2) to establish a framework of prospective multicenter data collection that can be expanded in the near
future. We will use a prospective observational cohort study design, enrolling patients from five centers prior to
surgical reconstruction for adult traumatic BPI. We will examine the criterion validity, responsiveness, and
appropriateness of the DASH, SF-36, and a BPI-specific, patient-reported outcomes instrument that our group
recently developed (“Impact of BPI” questionnaire). After we have completed the expected research, we will
have a well-validated outcome measure for the BPI population along with the ability to define which surgical
treatments provide meaningful improvement to patients.

Public health relevance
PROJECT NARRATIVE The loss of upper extremity use from brachial plexus injury can lead to disability, unemployment, emotional/psychological stress, and strained relationships with family/caregivers. We will investigate the best manner in which to measure outcomes after brachial plexus injury. With this information, we can better understand how to improve functional outcomes and return patients to being productive members of society.